Administrative Core

PROJECT SUMMARY / ABSTRACT ? ADMINISTRATIVE CORE The University of California San Diego Neuroscience Microscopy Imaging Core is a microscopy imaging center operating as one core. As such, there is only one combined Project Summary / Abstract in this application. Please refer to “Project Summary / Abstract ? Overall”.